Sleep, Brain Development, and Behavioral Correlates in a Longitudinal Cohort of Children at Risk for ASD

Project Summary
Children with autism spectrum disorder (ASD) are 2-3 times more likely to suffer from sleep
problems than typically developing children. Despite being a high priority population for sleep
research, and despite evidence that sleep problems have pervasive negative consequences for
health, behavior, mood, and cognition, the increased occurrence and clinical impact of sleep
problems in individuals with a family history of ASD is not well understood. This major public health
concern is the focus of our application, “Sleep, Brain Development, and Behavioral Correlates in
a Longitudinal Cohort of Children at Risk for ASD”. Problems with sleep initiation, circadian timing,
and inadequate amount of sleep in a high familial risk (HR) cohort of school-age children are
hypothesized to be preceded by altered brain and behavioral development in early childhood.
This proposal leverages a recently funded longitudinal follow-up of 7-10 year-old HR children and
children with low familial risk for ASD (LR) who have had multiple MRI and behavior assessments
since infancy through the NIH Autism Center of Excellence Infant Brain Imaging Study (IBIS). This
sample of 300 HR children includes ~100 diagnosed with ASD at 24 months, ~200 without a
diagnosis of ASD but with outcomes ranging from typical development to developmental and
psychiatric disorders known to occur at high rates in siblings of children with ASD, and 100 LR
children currently returning for assessment, including MRI, during school age. A biopsychosocial
model of pediatric sleep problems predicts that some combination of biological, environmental,
behavioral and psychiatric factors will account for the increased prevalence of sleep problems in
ASD, but it is unknown whether sleep problems are familial, endophenotypic, or disorder-specific
in this population. We propose to: (1) characterize circadian disturbances, sleep duration, and
other sleep parameters in the home using actigraphy, validated by sleep diary, and through parent
report of behavioral and medical sleep problems, (2) examine brain growth trajectories (from
infancy) associated with sleep problems in school-age, and (3) examine the longitudinal
behavioral and developmental trajectories and concurrent behavior associated with sleep
problems in school-age. Increased understanding of the neurobiology and developmental
characteristics of sleep problems in ASD has important implications for developing novel,
developmentally-sensitive sleep interventions which may help to reduce behavioral and health
problems exacerbated by sleep problems and improve outcomes in this vulnerable population.

Public health relevance
Project Narrative Pediatric sleep problems are a major public health concern and sleep in children with autism spectrum disorders (ASD) is a very high priority for research (see IACC Strategic Plan, Objective 2). Our application, “Sleep, Brain Development, and Behavioral Correlates in a Longitudinal Cohort of Children at Risk for ASD,” will leverage a recently funded longitudinal follow-up of 300 7-10 year-old children at high familial risk for ASD (HR; with ASD n~100; without ASD ~200) and 100 low familial risk for ASD (LR) who have had multiple MRI and behavior assessments since infancy through the NIH Autism Center of Excellence Infant Brain Imaging Study (IBIS). Across these three groups (HR-ASD, HR-NonASD, and LR) our aims are to 1) characterize sleep problems in the home using actigraphy, validated by sleep diary, and parent report, (2) examine longitudinal brain trajectories (from infancy) associated with sleep problems in school-age, and (3) examine the relationship of longitudinal behavior trajectories and concurrent behavior to sleep problems in school-age to increase understanding of the neurobiology, developmental characteristics, and co-morbid conditions associated with sleep problems, with implications for developing novel sleep interventions and improving outcomes in this vulnerable population.